Behavioral and Community-Based Research Shared Resource

PROJECT SUMMARY: BEHAVIORAL AND COMMUNITY-BASED RESEARCH SHARED RESOURCE
The Sylvester Comprehensive Cancer Center (Sylvester) Behavioral and Community-Based Research Shared
Resource (BCSR) supports a broad array of cancer research, including behavioral, psychosocial, clinical,
translational, and population studies in both community and clinic-based settings. The BCSR’s services are
fundamental to Sylvester’s strategic efforts to address the cancer burden within Sylvester’s South Florida
(SoFL) catchment area (CA), one of the most multicultural and multilingual diverse regions in the US. The
leaders of the BCSR are national experts in cancer disparities, health equity, community engagement,
qualitative and quantitative research methods, and translational science. BCSR services are defined through
the following aims: 1) coordinating the recruitment and retention of diverse study participants (e.g., diverse by
gender, race, ethnicity, sexual orientation, language, and socioeconomic status) that are representative of
SoFL; 2) supporting the development of culturally and linguistically tailored study materials, including
translation of informed consent forms and recruitment materials in Spanish and Haitian Creole; 3) facilitating
data and laboratory specimen collection in clinical and community settings; and 4) assisting with the
development and delivery of research interventions across the cancer continuum, from prevention to
survivorship. Consistent with the 2019-2023 Sylvester Strategic Plan, the BCSR increased the number and
capacity of study recruitment sites in clinic and community-based settings and established new services (e.g.,
biometric screening and medical record data abstraction). During the current reporting period (6/1/2018-
5/31/2023), the BCSR provided services to 40 Sylvester members from all Research Programs as well as 23
other principal investigators engaged in CA-relevant cancer research. Reflecting the critical importance of
BCSR services to Sylvester members, 91% of usage as measured by revenue was by members. Reflecting
the growing demand for services over the reporting period, there was a 52% increase in annual BCSR revenue
from Sylvester members. The BCSR accrued 5,767 study participants to 76 clinical research studies (including
57 studies led by members). Reflecting the diversity of Sylvester’s CA, 37% of these accruals were
Hispanic/Latino(a) (H/L), and 19% were Black. BCSR supported an additional 240 studies (688 study
documents) with translation services. The BCSR also facilitated collection of 5,188 laboratory specimens (e.g.,
blood and saliva) from research study participants. BCSR services facilitated 55 publications by members, of
which 20% (11 publications) were in high-impact journals (JIF ≥10). In alignment with the goals of the 2024-
2028 Sylvester Strategic Plan, future plans include further expanding BCSR recruitment and retention services
at Sylvester’s network locations and additional diverse community settings and expanding support for cancer
research using mobile health tools and devices.